Pennington MoTrPAC Adults - Renewal

MoTrPAC Project Summary
The Molecular Transducers of Physical Activity Consortium (MoTrPAC) is designed to discover and
characterize the range of molecular transducers that underlie the effects of exercise in humans. MoTrPAC
was launched in 2016 with six adult clinical centers and a pediatric center that have collaborated to
generate extensive Manual of Operations to guide research protocols involving all aspects of the clinical
operations (Phase I). Phase II began in the fall of 2019 with all human clinical centers showing excellent
progress towards initial recruitment goals and implementation of the protocol. The
NIH
that
exercise
initial goal set forth by
was to recruit 270 children (10-17 years of age) and 1980 sedentary adults (age 18 years or greater)
are andomized to endurance training ( 170 youth, 840 adults), resistance training (840 adults), or non-
controls (50 youth, 300 adults).
r
An additional group of highly active endurance (50 youth, 150
adults) and resistance (150 adults) trained individuals serve as comparators and are not participating in
the MoTrPAC exercise training programs. The recruitment and enrollment approach are sex balanced and
with participants across a wide range of ages (10-17, 18-39, 40-59 and >60-year age groups) and of
different races. Due to the COVID-19 pandemic, MoTrPAC activities were suspended for over a year
(beginning in March 2020) with continued constraints through 2022. Despite
encountered
(adult)
and
study.
the numerous challenges
as a result of the pandemic, the human clinical centers have successfully enrolled ~80%
and 95% (pediatric) of the highly active cohort, ~93% of cross-sectional (pediatric), and ~60% (adult)
~50% (pediatric) of the current target enrollment numbers in the randomized control trial portion of the
This led to the NIH Common Fund to release the current NOFO (RFA-RM-23-010) to provide
MoTrPAC with funding to complete
mechanistic
highly
exercise
extension
more
activity
recruitment and follow-up for the clinical studies, including finishing
randomized controlled trials of sedentary adults and children and observational studies of
active adults and children. This wil l enrich the articipant cohorts that are critical to understand
adaptations and heterogeneity across age, gender, and minority groups. Altogether, this
will allow MoTrPAC to complete the intended goals as riginally envisioned and will provide a
complete public database of the health benefits of exercise and provide insight into how physical
mitigates disease.
p
o

Public health relevance
MoTrPAC Narrative While there are many important health benefits of physical activity, how exercise exerts its effects is not fully understood. A more comprehensive understanding of the molecular mechanisms underlying the responses to exercise would significantly impact public health. Continuation of the Molecular Transducers of Physical Activity Consortium (MoTrPAC) will achieve its objective of generating a comprehensive map of the molecular responses to acute exercise and exercise training. with a long-range goal of elucidating the mechanisms by which exercise improves health.